MODULATION OF CORONARY AUTOREGULATORY RESPONSES

The overall objective is to study factors which modulate coronary autoregulatory responses to both acute and chronic reductions in coronary pressure in conscious dogs by addressing the following specific aims: I. Determine intrinsic metabolic and extrinsic vascular factors which modulate coronary autoregulatory responses to acute changes in coronary pressure in the awake dog. II. Determine the effect of oxygen delivery on coronary autoregulation in the awake dog. III. Characterize coronary autoregulation in "stunned myocardium" following transient coronary occlusion. IV. Examine chronic adaptations in regional flow, subendocardial function and myocardial metabolism to reduced pressure in a model of collateral-dependent myocardium. The experiments will examine interrelationships among coronary pressure, transmural myocardial perfusion and regional subendocardial function using the latter parameter as an index of the adequacy of subendocardial oxygen delivery. They will test the hypothesis that intrinsic myocardial metabolic demand and extrinsic vascular factors influence the characteristics of autoregulation. They will also examine the role of oxygen delivery on the characteristics of autoregulation and determine the functional consequences of reduced coronary pressure and flow. The studies will provide new knowledge regarding coronary autoregulation in post-ischemic regional myocardial dysfunction. Finally, the response of regional coronary flow and myocardial function during chronic reductions in coronary artery pressure in collateral-dependent myocardium with limited vasodilator reserve and depressed resting regional function will be defined. These latter studies are likely to extend our knowledge of coronary autoregulation and regional function during acute reductions in coronary pressure to a situation that more closely resembles the chronic pressure reductions distal to coronary artery stenoses which occur in man. These are likely to stimulate adaptations involving changes in myocardial metabolism and possibly chronic changes in regional muscle performance.